Administrative Core

Project Summary: The Administrative Core (ADM) of this new University of Rochester (UR) IDDRC
application serves as the main coordination hub of a fully integrated system of four scientific cores that support
the crucial work of 105 UR-IDDRC investigators currently prosecuting 202 basic, translational and clinical
research projects in the domain of IDD research. These cores are: Human Phenotyping & Recruitment (HPR);
Translational Neuroimaging & Neurophysiology (TNN); Cell & Molecular Imaging (CMI); and Animal Behavior
and Neurophysiology (ABN). The ADM Core brings together two international leaders in the field of IDD
research, Professors John Foxe and Jonathan Mink, both with a wealth of complementary leadership
experience, to coordinate and prosecute this effort. In consultation with the UR-IDDRC community, they have
formulated a clear and progressive mission of excellence in IDD research, one that places the people we
serve, those with an IDD, at the heart of our Center, and one that promotes equity, inclusion, diversity, and
cultural/linguistic competence. The ADM leadership has identified five thematic research clusters that serve to
coalesce our portfolio into a coherent well-articulated IDD program, and around which we will build our future.
These are: (1) Rare & Orphaned Diseases of Neurodevelopment; (2) Parental Stress & Early Life Exposure as
Determinants of Brain Development; (3) Neuroinflammatory Mechanisms in Pathological Brain Development;
(4) Autism Spectrum Disorder; and (5) Multisensory & Sensorimotor Integration. The ADM coordinates a
substantial pilot grant program, supported through extensive philanthropic efforts and substantial University
support, distributing $400,000 per annum in a highly competitive program designed to promote high-risk high-
return IDD projects. We have set in place an innovative system of educational activities for pre- and post-
doctoral trainees, and a substantial dissemination effort that includes multiple online social media outlets (with
closed captioning in Spanish, and ASL translators at live events), an effort that has been specifically designed
to be consumable by the public. The ADM coordinates a major data archiving and sharing effort across the
Cores, interfacing with the UR CTSI and leveraging our state-of-the-art Bio-Lab Informatics System (BLIS).
The Core has established reportage and systematic assessments that continuously scrutinize and evaluate the
functioning of the center, ensuring that efficiency and cost-effectiveness are maintained at the highest levels
and that the Cores evolve to be fully responsive to changes in technology and systems. The ADM is supported
by five key advisory committees that provide crucial input regarding ongoing functioning of the center. These
are: (a) The Executive Committee; (b) The External Advisory Board; (c) The Parent and Community Advisory
Board; (d) The Internal Advisory Board; and (e) The Core Facilities Management Committee. We stand
committed to a clear-eyed purpose, that through our science, we will endeavor each and every day to remove
impediments facing people with IDD that prevent them from living the healthiest, most fulfilling lives possible.